Mechanisms of Nuclear Migration

Summary
Proper nuclear positioning is central to many cellular and developmental events. We focus on the roles of linker
of nucleoskeleton and cytoskeleton (LINC) complexes and nuclear lamins in mediating nuclear positioning. LINC
complexes are formed by the interaction between KASH proteins in the outer nuclear membrane and SUN
proteins in the inner nuclear membrane. The nucleoplasmic domains of SUN proteins interact with nuclear lamins
and chromatin. Our preliminary data show that LINC complexes regulate cytoplasmic macromolecular crowding,
which is important for many biochemical reactions and phase separations. Our goal is to address knowledge
gaps in two research themes. In the first theme, we address how LINC complexes and parallel pathways mediate
nuclear positioning. We do not understand how nuclei determine which direction to move on microtubules, a
basic question in the intracellular trafficking of many cargos. We hypothesize that specific isoforms of the KASH
protein UNC-83 direct nuclear migration at different developmental stages; a short UNC-83 isoform activates
kinesin-1, while a longer isoform favors dynein motors. We also do not understand how nuclei are deformed to
squeeze though small constrictions, a hallmark of the immune response and metastasis. In our working model,
four parallel pathways function to deform and protect nuclei, including LINC complexes and dynein, FLN-2
through unknown mechanisms, heterochromatin anchored to the nuclear periphery, and a Cdc42/actin pathway.
We developed an in vivo model, where C. elegans larval P-cell nuclei migrate through narrow constrictions as
part of normal development. We combine forward genetics, live imaging, and in vitro microtubule motor assays
to address these questions. In research theme 2, we address how LINC complexes regulate the biophysical
properties of the cytoplasm during development. Our studies are based on our unexpected findings that the giant
KASH protein ANC-1 functions to anchor the endoplasmic reticulum (ER), lipid droplets, mitochondria, and nuclei
by preserving the mechanical properties of the cytoplasm. In our model, ANC-1 maintains ER morphology
through its spectrin repeats acting as a scaffold for the ER. Furthermore, ANC-1 works through LINC complexes,
lamins, and ribosomes to regulate cytoplasmic macromolecular crowding. To test our model, we combine
developmental and biophysical approaches to perform passive rheology experiments in C. elegans tissues by
expressing genetically encoded macromolecular nanoparticles (GEMs) and measuring their diffusion rates in the
cytoplasm. Disrupting LINC complexes, ribosomes, or lamins leads to significantly decreased cytoplasmic
macromolecular crowding, which could affect reaction rates, cellular mechanics, and phase separations. The
significance of our research lies in its potential to shed light on the molecular basis of a wide range of human
diseases associated with LINC complex dysfunction, including cancer, infertility, muscular dystrophy, and
neurological disorders. The innovative combination of developmental and biophysical approaches positions our
studies to provide novel insights into cellular architecture, developmental processes, and disease pathogenesis.

Public health relevance
Project Narrative LINC complexes play important cellular functions including nuclear positioning, homolog pairing in meiosis, DNA damage repair, wound healing, spermatogenesis, mechanotransduction, and the formation of nuclear pore complexes. The proposed research is relevant to public health because mutations in LINC components are associated with a wide variety of human diseases including muscular dystrophies, neurological disorders, Progeria, aneurysms, hearing loss, hearing loss, sterility, and cancer.